Responses to Hybrid Insulin Peptides as Biomarkers of Disease Activity in Human Type 1 Diabetes

Abstract: T Cell Responses to Hybrid Insulin Peptides as Biomarkers of Disease Activity in
Type 1 Diabetes
An important objective in T1D research is the investigation of autoantigens that activate effector T cells
and trigger the inflammatory process in islet beta-cells. We recently identified Hybrid Insulin Peptides
(HIPs) as a new class of autoantigens in type 1 diabetes (T1D). These neoantigens are created by the
fusion of insulin fragments with peptides from other secretory granule proteins such as chromogranin
A (ChgA), islet amyloid polypeptide (IAPP), neuropeptide Y (NPY) or insulin itself. Because insulin is
present only in pancreatic beta cells, this discovery might provide an explanation for organ-specific
autoimmunity in T1D. Importantly, CD4 T cells responding to HIPs have been isolated from the islets
of deceased T1D patients, demonstrating the relevance of these autoantigens to the human disease.
We hypothesize that T cells reactive to HIPs can serve as biomarkers of disease. Our goals in this
project are (1) to characterize T cell responses to HIPs in the PBMCs of T1D and controls; (2) to
determine the extent of reactivity to insulin B:9-23 Hybrid Insulin Peptides in recent onset T1D patients;
(3) Investigate the presence and phenotype of HIP-reactive T cells in the natural history of T1D.

Public health relevance
PROJECT NARRATIVE Baker, UC Denver – School of Medicine – Dept. of Immunology and Microbiology This projects aims to gain better understating of T cell reactivity in the context of type 1 diabetes. Knowledge from these studies may improve our understanding of the underlying autoimmune disease process and may ultimately lead to antigen specific therapies that may change the course of this difficult clinical disease.